Administration

PROJECT SUMMARY (See instructions): The ongoing goals of CORE A will be: 1) to provide generalized administrative support, 2) to insure efficient and appropriate usage of core services by the individual projects, 3) to coordinate and organize monthly research meetings of the program investigators, 4) to provide mechanisms of conflict resolution and potential rebudgeting issues, 5) to provide constructive review of the research through Internal and External advisory committees, 6) to provide budgetary services, such as tracking the expenditures of the program and providing monthly reports to the investigators, 7) to provide an objective quality assurance program that will monitor the clinical trials, and 8) to provide assistance and coordination with regulatory agencies within the Penn campus and with the FDA and R.A.C. The administrative functions (Goals 1-5) will be accomplished using a structure in which the Core Leader, Dr. Albelda, is advised by an Executive Committee of Project and Core Leaders with input from Internal and External Advisory Committees. He will be assisted by an administrative assistant, Ms. Pelzer. The budgetary goal (Goal 6) will be performed by Ms. Lavinia Pritchett. She will be responsible for facilitating communication and will have budgetary responsibility with oversight from Dr. Albelda. To provide an objective quality assurance program that will monitor the clinical trials, and to provide assistance and coordination with regulatory agencies within the PENN campus and with the FDA and R.A.C. (Goals 7 and 8), the Core will continue to utilize Penn's Office of Human Research and a regulatory consultant, Mr. Phillip Cross.

Public health relevance
RELEVANCE (See instructions): Malignant mesothelioma is currently considered incurable. New approaches are needed. This Core provides the administrative infrastructure to support the clinical and preclinical studies of the Program Project.